Alleviation of chronic TBI through modulation of calcium signaling

Project Summary: Growth hormone deficiency (GHD) due to chronic traumatic brain injury (TBI) is common
among the veterans from the wars in Iraq and Afghanistan. Such condition develops as a result of
hypothalamic-pituitary axis (HPA) dysfunction leading to reduced growth hormone (GH) levels, which pose a
significant impact on their quality of life due to medical, psychological, and psychiatric consequences. The GH
replacement therapy in post-traumatic GHD, in most cases, do not produce the desired clinical outcome.
Analysis of the signs and symptoms of HPA dysfunction suggests that compromise in GH secretion may be as
a result of defective upstream hypothalamic signaling. Thus, we propose to restore the hypothalamic-
neurotropic stimulation by endogenous GH secretion from the surviving (post-TBI) anterior pituitary cells
(somatotrophs), leading to axonal regeneration of TBI-damaged neurons. Although intracellular calcium ion
(Ca2+) concentration ([Ca2+]i) can regulate hormone release, the ion channel responsible for increasing [Ca2+]i
the GH release in pituitary somatotrophs is unknown. Our ongoing studies have identified that activation of
Transient Receptor Potential Canonical 3 (TRPC3), a Ca2+ influx channel, facilitates vesicle-associated soluble
N-ethylmaleimide-sensitive factor attachment protein receptor (SNARE) protein complex interactions, which is
necessary for hormonal release. Moreover, disruption of TRPC3 markedly attenuated [Ca2+]i entry, which is
essential for GH secretion and axonal regeneration. Thus, our central hypothesis is that the agonist activation
of TRPC3 in pituitary cells triggers Ca2+ entry, resulting in enhanced GH secretion, which will help to
regenerate those damaged axons in the adjacent HPA region. We propose to study the following two Aims
using an established controlled cortical impact (CCI)-induced injury mouse model of TBI: (1) Characterization
of the role of TRPC3 in regulating GH secretion by examining the functional restoration of hypothalamic
neurotropic connections in TBI; and (2) Determine that TRPC3 activation stimulates axonal regeneration in
TBI-damaged neurons and examine a “proof of concept” that augmenting TRPC3 expression/activation
ameliorates chronic neurobehavioral abnormalities. We will perform a series of behavioral tests such as Morris
water maze for memory and beam walk test to assess sensorimotor coordination and motor learning for
correlating the behavior with brain neurochemistry. The results of the present study will: i) find the novel
mechanism of TRPC3-induced GH secretion essential for axonal growth and regeneration that can be used as
a tool to identify potential new therapeutic options; ii) elucidate the molecular pathogenesis of GH secretion
following chronic TBI; and iii) help to plan and execute future investigations to improve and manage TBI-
induced GHD and neurobehavioral abnormalities in both veterans and civilians.

Public health relevance
Growth hormone (GH) deficiency due to hypothalamic-pituitary axis dysfunction in traumatic brain injury (TBI) is common among veterans of the wars in Iraq and Afghanistan. Such condition contributes to chronic neurobehavioral abnormalities for example memory dysfunction, depression, anxiety, and fatigue, leading to cognitive impairment and reduced quality of life. The only treatment option available for these patients is GH replacement, which in most cases has serious side effects and do not produce the expected clinical outcome. Interestingly, post-traumatic neuroendocrine abnormalities occur early, and finding disrupted upstream signaling mechanisms that govern the secretion of GH, which we propose to accomplish, could significantly contribute towards the recovery and rehabilitation of these patients with TBI. The proposed study will identify the potential new therapeutic options for these TBI patients by restoring the upstream signaling connections, normalize GH levels, and improve the quality of life.